Growing Xylazine Supply in NC: A Community-Based Investigation of Exposure and Health Consequences

PROJECT SUMMARY/ABSTRACT
We propose a community-based, longitudinal, mixed-methods study to investigate the growing crisis of
xylazine exposure among people who use drugs (PWUD) in the southeastern US. The Office of National
Drug Control Policy recently listed xylazine as an emerging threat and the Centers for Disease Control and
Prevention (CDC) warned of xylazine’s growing involvement in fentanyl overdose deaths. Among all US
regions in 2020–2021, the south experienced the largest increase in xylazine-involved overdose (OD) deaths
and the largest rise in xylazine-positive drug seizures. Yet, there remains a paucity of information on
adulteration patterns in local markets, the impact of (un)witting exposure among consumers, how consumers
are responding to xylazine, and drug use behaviors placing people at increased risk for atypical ODs and
novel wounds. CDC recommends testing illicit drugs for xylazine to clarify prevalence in drug supplies and
provide actionable intelligence to inform response. Community-based drug checking (CBDC) will expand the
scientific impact of the proposed study by allowing us to identify patterns of xylazine adulteration within and
across drug classes without having to rely on self-report to identify study participants exposed to xylazine,
thus strengthening our scientific capacity to measure its psychosocial and physiological impact. Aim 1: To
employ CBDC to determine xylazine’s overall prevalence in the illicit drug supply and its relative prevalence
in specific drugs consumed by study participants; Aim 2: To explore knowledge and discernment strategies
among consumers of illicit drugs as they navigate an illicit drug supply increasingly adulterated with xylazine;
Aim 3: To examine the drugs and drug use behaviors of PWUD to determine the psychosocial
consequences, behavioral risks, and adverse sequalae associated with xylazine exposure; Aim 4: To
disseminate real-time CBDC results (Aim 1) and rapidly-analyzed study findings (Aims 2–3) to the
state/county health departments and community-based organizations to inform public health response
. To achieve these aims, we will recruit PWUD from two study sites and their surrounding counties. The
study will be led by Principal Investigator Jon Zibbell, a National Institute on Drug Abuse–funded behavioral
scientist with many years of experience studying injection drug use and infectious disease risk among
PWUD. The team also includes Arnie Aldridge, a National Institutes of Health–funded statistician; Bradley
Ray, a research sociologist; and Sarah Duhart Clarke, an applied psychologist. Findings from the proposed
study will help clarify prevalence of xylazine and illicit markets and identify associated behaviors,
observations, and adverse sequalae by Drug, Set, and Setting factors. The proposed study is poised to
directly inform local and national efforts for combatting harms associated with xylazine use by disseminating
findings to community members and decisionmakers in real-time.

Public health relevance
PROJECT NARRATIVE The proposed mixed-methods study will investigate xylazine’s growing prevalence in the illicit drug markets in the Appalachian foothills of North Carolina and investigate its epidemiological impact on consumer perceptions, behavior, and health. Knowledge gained from this study will clarify xylazine’s overall prevalence in the illicit drug market and its relative prevalence in specific drugs; identify consumers’ homegrown strategies for discerning xylazine in their drugs; and identify Drug, Set, and Setting (DSS) risk factors, psychosocial consequences, behavioral risk, and adverse health outcomes associated with xylazine exposure. Because the sharp growth in xylazine exposure among people who use drugs comprises an emerging health crisis, this study will directly inform local and national efforts for combatting harms associated with xylazine use by disseminating findings to community members and decisionmakers in real time.